Role of PKC Epsilon in Atheroprotection

PROJECT SUMMARY
Cardiovascular disease afflicts approximately 50% of older Americans and is the major cause of death
worldwide. It is a chronic inflammatory disease in which macrophages (MØ) play a central role; their deletion
reduces plaque size and composition. Usually, inflammation is self-limiting, with resolution following initiation.
In atherosclerosis this yin and yang is out of balance, with MØ failing to shift towards resolution. While many of
the players in the inflammation (cytokines, chemokines) and resolution (specialized pro-resolving lipids
including RvD1) phases have been identified, the intracellular signaling network that links uptake of oxLDL to
resolution, and the roadblocks to that resolution in atherosclerosis, remain to be defined. Preliminary data
implicate PKCe in both inflammation and resolution by restricting excessive inflammation while promoting
release of specialized pro-resolving lipid mediators (SPM). However, how PKCe achieves this is a fundamental
unanswered question. We generated a PKCeloxP/loxP mouse that was crossed with LysM Cre to generate a novel
strain in which PKCe is selectively deleted in the myeloid lineage (meKO). When made hypercholesterolemic,
meKO mice have significantly more plaque than WT animals. This result implicates myeloid PKCe as a novel
atheroprotective gene. Using our meKO mice we will test the hypothesis that myeloid PKCe contributes to
inflammation but also signals in the production of SPM, thus promoting resolution; its absence sustains
inflammation and reduces resolution thereby exacerbating atherosclerosis. The hypothesis will be tested in
vitro and in vivo. In vivo experiments include zymosan peritonitis, a self-resolving inflammation that will enable
us to determine where PKCe acts along the inflammation"resolution axis. Cells and peritoneal lavage fluid will
be recovered over time (4-72 h). Cell metrics include number and ratio of neutrophils to macrophages (MØ)
and the polarization state of the MØ. Lavage fluid will be assayed for cytokines, chemokines, and SPMs.
Secondly, archived aortic roots from hypercholesterolemic WT and meKO mice will be analyzed for histological
differences (eg, localization and polarization state of MØ, amount and location of collagen, amount of necrosis
and apoptosis.) Finally, in vitro studies will define the differences in the responses of WT and meKO MØ to
oxidized LDL and during efferocytosis. Understanding how PKCe acts in inflammation and resolution may
reveal novel nodes of regulation that can be therapeutically targeted to promote resolution in the context of
hyperlipidemia. In conclusion, our findings will provide the foundation upon which to build a more mechanistic
grant to understand how PKCe signals during the shift from inflammation to resolution. Translationally, the
results may be applicable to those diseases in which PKCe is dysregulated and MØ play a prominent role (eg,
cancer, scleroderma, Alzheimer’s, atherosclerosis, etc.).

Public health relevance
Project Narrative We generated a PKCe flox’d mouse that, when crossed with LysM Cre, selectively deletes PKCe in the myeloid lineage (meKO). Hypercholesterolemic meKO mice have exacerbated atherosclerosis. This R21will investigate the effects of PKCe expression on resolving inflammation, efferocytosis, lipid handling and plaque histology.